Role of the FAAH-OUT locus in cutaneous wound healing

RESEARCH SUMMARY
The proposal will study the unusual phenotype of a 69-year-old woman who displays exceptionally
accelerated skin wound healing with minimal scarring. Genome sequencing revealed that her
phenotype is caused by an ~8 kb deletion downstream of the fatty acid aldehyde hydrolase
(FAAH) gene that results in the loss of a long noncoding RNA (lncRNA) gene named FAAH OUT.
The goal of this proposal is to understand how the FAAH OUT deletion results in accelerated
wound healing. In the United States, the annual medical burden of chronic wounds exceeds $25
billion and continues to rise with the aging population. There is a critical need to improve
understanding of the biological processes underlying skin wound healing and to innovate new
therapies. In the first aim, we will study normal and wounded skin tissue from the study subject
using spatial transcriptomics, in situ hybridization, and xenograft skin repair models to understand
how the FAAH OUT locus regulates wound healing. In the second aim, we will elucidate the FAAH
OUT genetic interactome to gain insight to its molecular mechanisms. By studying a rare genetic
allele of an individual with markedly enhanced wound healing, this proposal aims to generate
novel insight to the role of lncRNAs in wound repair and discover new human-validated targets to
treat cutaneous wounds.

Public health relevance
RESEARCH NARRATIVE Many skin wounds do not heal properly. This grant will study the genetics of an unusual woman who has an enhanced ability to heal from skin injuries with a minimum of scarring. By understanding how her body is able to repair the skin so well, we hope to learn new therapeutic targets that could lead to new therapies for wound healing.